Admin Core

ADMINISTRATIVE CORE PROJECT SUMMARY
The Administrative Core is critical to facilitating the mission of the HHEAR Data Center, to provide logistical
and intellectual support for the maintenance, analysis, interpretation, curation, and reuse of data generated by
HHEAR. The Administrative Core will provide administrative and organizational management of the Data
Repository and Management Core, Data Science Resource, and Statistical Services and Analysis Resource by
serving as the primary interface between the Data Center and other units of the overall HHEAR Network (i.e.,
the HHEAR Coordinating Center and the HHEAR Exposure Assessment Laboratory Network). Further, Data
Center leadership are committed to the FAIR principles, and thus we will strive to make HHEAR data as
findable, accessible, interoperable, and reusable as possible. Additionally, considerable effort will be focused
on the technical development of biomedical vocabulary/ontology data standards and the management of
community-driven standards development. A unique Translation and Engagement group within the
Administrative Core has been designed to develop, implement, and coordinate the dissemination and
engagement activities within and across each resource of the HHEAR Data Center. This will allow us to
achieve our goal of ensuring that HHEAR data and resources fulfill the FAIR principles and will be of
immediate relevance to our stakeholders. Through these efforts, the HHEAR Data Center will ensure that
research will advance quickly and efficiently toward a better understanding of the environment and human
health across the lifecourse. The Administrative Core provides essential support to meet these goals.
Additionally, leveraging our existing infrastructure and expertise will overcome the need for a long
implementation process fraught with challenges — we have already encountered and overcome many such
challenges in implementing the CHEAR DC, and will be able to flexibly respond to the needs of the HHEAR
Network.